Manipulation of the host cell inflammasome by Mycobacterium tuberculosis

Abstract
Mycobacterium tuberculosis (Mtb) causes pulmonary tuberculosis (TB) in humans. In 2017 alone,
~10.0 million new cases were reported, leading to approximately ~1.3 million deaths. There are no
effective vaccines for TB and only sub-optimal chemotherapeutics exist. IL-1 is a cytokine that
increases host resistance against Mtb infections. Mtb is able to limit the amount of IL-1 production
by inhibiting the host cell inflammasome activation. There is a gap in our understanding of how Mtb
exploits host cell signaling in order to inhibit the activation of the inflammasome. We describe for the
first time that Mtb can inhibit the activation of the NLRP3 inflammasome and we identified the first
Mtb gene (PknF) important for this inhibition. We performed a gain-of-function genetic screen and
identified 5 other genomic regions of Mtb mediating the inhibition of the AIM2 inflammasome. We
think that the discovery of specific Mtb genes involved in inhibiting the host inflammasome activation
(Specific Aim 1) will allow for the characterization of the molecular mechanisms of inhibition (Specific
Aim 2) and for testing their importance for virulence of Mtb (Specific Aim 3) during the course of the
research proposal. We believe that our findings will have great translational potential since a greater
understanding of the molecular mechanisms of host cell inflammasome activation will provide
novel targets for development of adjunctive Mtb drugs and of host-directed therapeutics.

Public health relevance
Narrative Mycobacterium tuberculosis (Mtb) causes 10 million new cases of tuberculosis and 1-2 millions deaths annually. We will characterize how Mtb regulates the host cell inflammasome to increase its virulence. The results of our research may lead to the discovery of important new targets for drug development and host-directed therapeutics.